Investigating the Functions of RME8 in Parkinson's Disease

SUMMARY
The DNAJC protein family (DNAJC5-26) is a subclass of co-chaperones that has attracted recent attention due
to the identification of mutations that are linked with parkinsonism. Here, we focus on DNAJC13, which encodes
Receptor-Mediated Endocytosis 8 (RME8), a co-chaperone that facilitates membrane recycling and cargo sorting
of endocytosed proteins. RME8 is primarily localized at the early endosome membrane which serves as a
switchboard for protein and membrane traffic. In Parkinson’s disease (PD) patients, different mutations of RME8
have been identified, however, more evidence are needed to understand the roles of RME8 in Parkinsonism in
vivo. Our proposal will systematically evaluate the 1) behavioral, 2) pathological and 3) cellular changes in novel
RME8 mouse models, as a function of age, and determine if they replicate PD features. Our objective is to define
the functions of RME8 in Parkinsonism and identify points of therapeutic intervention for PD.

Public health relevance
PROJECT NARRATIVE DNAJC13, which encodes Receptor-Mediated Endocytosis 8 (RME8), is a synaptically enriched co- chaperone that functions in clathrin-mediated transport and membrane recycling. Here, we will characterize the role of RME8 in Parkinsonism.